Targeting chromatin acetylation factors in multiple myeloma

PROJECT SUMMARY
Multiple myeloma is a disease characterized by aberrant chromatin accessibility and gene expression. Principle
mediators of this dysregulation are chromatin regulators that coordinate transcription through enhancer
activation. Our recent efforts have led to the creation of chemical 'degrader' tools that specifically target two
enhancer-activating chromatin regulators critical for the survival and proliferation of multiple myeloma cells, CBP
and p300. While inhibitors of these factors have recently begun to undergo clinical investigation, the central
hypothesis of this project is that pharmacologic degradation offers a superior strategy for treatment. To
interrogate the unique mechanisms of CBP/p300 degradation in myeloma and to credential these new chemical
tools as candidates for therapeutics development for multiple myeloma patients, we will prosecute the following
two specific aims: Aim 1 will use CBP/p300 inhibitors and degraders to assess comparative consequences of
CBP/p300 perturbation in multiple myeloma cells. For this aim we will utilize a variety of epigenomic,
transcriptomic, and chromatin conformation assays to describe the primary acute effects of these drugs. We will
also systematically interrogate the unique consequences of CBP and p300 loss alone using selective
degradation tools. Aim 2 will use xenograft models of multiple myeloma to determine the optimal dosing and
drug-drug combinations required for CBP/p300 degraders to induce tumor regression in vivo. These studies will
be performed using a variety of multiple myeloma model systems that display variable sensitivity and resistance
profiles to CBP/p300 inhibitors. We expect that these efforts will reveal mechanisms of gene regulatory
dysfunction in multiple myeloma, describe in high resolution the effects of a drug currently undergoing preliminary
clinical investigation, and nominate a promising new class of chemical degraders for the treatment of this deadly
disease.

Public health relevance
PROJECT NARRATIVE Multiple myeloma is a disease characterized by aberrant gene expression mediated by faulty epigenomic signaling. Our research aims to develop new therapeutics that target factors driving this malfunctioning expression. This project aims to provide mechanistic understanding of myeloma cell dependency on critical epigenomic regulators that activate genomic enhancer elements, and credential novel chemical degraders of these factors as potential therapeutics.